IDeA National Resource for Quantitative Proteomics

ABSTRACT
Through PAR-19-301, NIGMS seeks to support mission relevant resources that will have the economy of
scale to provide increased access to state-of-the-art services for a substantial regional or national user base. In
response, we are applying for NIGMS National Resource support for the IDeA National Resource for Quantitative
Proteomics. This resource was created in 2016 using NIGMS-funding from the IDeA (Institutional Development
Award) Program that supports research in 23 states and Puerto Rico that have historically received lower levels
of NIH funding. The IDeA National Resource for Quantitative Proteomics was created by regional consolidation
of instrumentation, proteomics expertise, and associated bioinformatics resources across Arkansas and
Oklahoma. The resource was created because IDeA investigators across the United States can face specific
challenges for accessing cutting-edge proteomics resources and bioinformatics expertise for data interpretation.
These challenges include the cost of rapidly advancing instrumentation, availability of the personnel expertise
those instruments demand, and access to bioinformaticians trained in proteomics. Arkansas and Oklahoma were
positioned to unify their respective infrastructures to fill these resource gaps and provide a comprehensive
solution for quantitative proteomics to the IDeA network. Our resource has had three years to become fully
established and reach economy of scale. We have served a diverse set of IDeA investigators for their NIGMS
relevant research, ranging from studies on model organisms to diseases such as cancer. The goal of this
proposal is to transition the IDeA National Resource for Quantitative Proteomics to a NIGMS National Resource
in order to expand our ability to serve the quantitative proteomics needs of the IDeA network. We will continue
to provide user-friendly services for state-of-the-art, quantitative proteomics that will guide the user from service
request to sophisticated bioinformatics analysis to delivery of publication ready data. This resource will continue
to support the biomedical research mission of NIGMS and NIH for both fundamental and translational research
focused on human diseases including cancer. We will use the following Specific Aims to accomplish our goal: 1)
Provide state-of-the-art quantitative proteomics services to the IDeA network, 2) Provide outreach opportunities
for quantitative proteomics to the IDeA network, and 3) Provide educational opportunities for quantitative
proteomics to the IDeA network.

Public health relevance
NARRATIVE Defined regions of the United States that have historically received lower levels of NIH funding face specific challenges for accessing key research resources to facilitate biomedical research within the mission of the National Institute of General Medical Sciences (NIGMS). To alleviate one such challenge in these regions, we will provide access to a national quantitative proteomics resource through the IDeA National Resource for Quantitative Proteomics. We will provide investigators in these regions of the United States access to user- friendly services for state-of-the-art, quantitative proteomics that will guide the user from service request to sample analysis to delivery of publication ready data.